Circadian Clock Regulation of HIF1a-dependent Skeletal Muscle Metabolism during Diet-induced Obesity

Project Summary
The mammalian circadian clock is comprised of an autoregulatory transcription-translation feedback loop
expressed in the brain and peripheral tissues that coordinates metabolism with the sleep-wake cycle.
Epidemiological and genetic studies have shown that disruption of circadian rhythms leads to accelerated and
worsened symptoms of metabolic syndrome. Evidence from skeletal muscle clock mutants in lean mice indicates
that loss of clock activators leads to impaired glucose tolerance and reduced insulin-stimulated glucose uptake.
Additionally, our lab has shown that genetic abrogation of the skeletal muscle molecular clock in vitro leads to
skeletal muscle dysfunction due to reduced mitochondrial oxidative respiration and impaired activation of the
hypoxia-inducible factor (HIF) pathway. My preliminary data demonstrate that during the nutrient stress condition
of diet-induced obesity (DIO), HIF1α pathway target gene expression is elevated in skeletal muscle and loss of
clock activator, BMAL1, leads to reduced HIF1α pathway target gene expression and impaired glucose tolerance
in mice. Additionally, the clock-disrupted mice have reduced muscle mass which may be a preliminary sign of
sarcopenia. We generated clock-disrupted HIF1α stabilized mice to determine whether this could rescue the
muscle phenotypes seen in the clock-disrupted mice. Glucose tolerance and HIF1α target gene expression were
rescued in the HIF1α stabilized mice. These data suggest that the skeletal muscle molecular clock regulates
glucose metabolism through the HIF pathway, however, the specific mechanisms of this regulatory interaction
and the role of HIF1α in maintaining muscle mass remain unknown. The scientific premise of the present
proposal is that the skeletal muscle molecular clock controls whole-body glucose metabolism and skeletal
muscle metabolism during DIO through regulation of HIF pathway transcription. The studies in this proposal will
provide greater insight into clock control of skeletal muscle metabolism during nutrient stress and elucidate the
mechanism of interaction between the skeletal muscle molecular clock and HIF pathways.

Public health relevance
Project Narrative Understanding the link between genetic and environmental influences on the development of metabolic syndrome is crucial to developing better therapies for treatment and prevention. While studies have implicated the disruption of natural circadian rhythms with accelerated and increased rates of metabolic disease, our understanding of the biological mechanisms driving this phenomenon are limited. This proposal seeks to elucidate the role of the skeletal muscle-autonomous molecular clock in muscle metabolism and the development of glucose intolerance through understanding the mechanism of interaction between the molecular clock and hypoxia-inducible factor response pathway.